POCTRN SUPPORT - COORDINATION CENTER

The overall objective of the Point-of-Care Technologies Research Network (POCTRN) is to support the rapid development, commercialization, and implementation of innovative point-of-care and home-based diagnostic technologies. As a national resource, the Network model creates a multidisciplinary coalition of knowledge and capabilities that can be leveraged to accelerate technology development, with the fundamental goal of broadly enhancing access to diagnostic technologies. The Network will consist of multiple Technology Research and Development Centers (TRDCs), each with expertise in specific technical and/or clinical areas and each covering multiple levels of technology readiness, which will collaborate through a Coordination and Technology Support Center (CTSC). The TRDCs will engage government, industry, or other organizations, including various departments from academic institutions, that can partner to provide synergistic resources to support the development of new technologies and solutions.